Individualizing pharmacotherapy: A novel optimization strategy to increase smoking cessation in the African American community.

PROJECT SUMMARY/ABSTRACT
African American (AA) smokers bear a disproportionate share of tobacco-related morbidity and mortality. Quitting
smoking is the single most important change a smoker can make to improve their health, yet AA experience
greater difficulty quitting relative to other racial/ethnic groups despite being lighter smokers (< 10 cigarettes per
day; CPD) and making more attempts. In the majority of smoking cessation trials, participants stay on the
pharmacotherapy to which they were randomized through the end of the study. These trials do not provide any
opportunity to make changes to pharmacotherapy during the course of treatment despite evidence that the
smokers who fail to achieve abstinence within 4 weeks of initiating treatment never achieve long-term
abstinence. Optimized approaches that change or augment pharmacotherapy have been successfully used in
other disciplines but are relatively new to tobacco dependence research. Given that tobacco dependence is a
chronic, relapsing disorder characterized by multiple failed quit attempts, the high degree of heterogeneity in
treatment response, and the absence of new pharmacotherapy advances, the best opportunities to improve
tobacco treatment for AA smokers lie in the use of novel methodologies that explore how to optimize treatment
by providing intensive smoking cessation counseling while altering the timing, sequencing, or combining of
pharmacotherapies to maximize efficacy. The objectives of this application are to 1) evaluate short- and long-
term efficacy of optimized (OPT) versus enhanced usual care (UC) treatment on biochemically-verified 7-day
abstinence in African American smokers, 2) identify mediators and moderators of treatments effect on
abstinence, 3) characterize the proportion of subjects requiring optimization and the rate of verified abstinence
along each optimization pathway, and 4) characterize treatment process factors (e.g., withdrawal, craving) over
time in response to optimized treatment. These objectives will be accomplished through a randomized open-
label optimized treatment trial for smoking cessation in 392 African American smokers. Participants
randomized to OPT (n=196) will receive smoking cessation counseling, nicotine patch, and up to two
pharmacotherapy adaptations to bupropion and/or varenicline based on verified smoking status at Weeks 2
and 6. Participants randomized to enhanced UC (n=196) will receive the same smoking cessation counseling
and nicotine patch; no adaptations in pharmacotherapy will be made. At the conclusion of the trial we will
provide the research and clinical communities with knowledge about the efficacy of optimized versus non-
optimized approaches for achieving short- and long-term abstinence for AA , as well as an understanding of the
mediators and moderators of treatment effect. The innovative study design evaluates a major shift in the
approach to tobacco dependence treatment and, if effective, could have broad treatment implications for the
nearly 6 million AA adult smokers in the U.S.

Public health relevance
PUBLIC HEALTH RELEVANCE Improving cessation outcomes for African American smokers through the use of novel, empirically-based strategies is a national health priority. In the vast majority of smoking cessation studies and in clinical practice, when smokers are provided a medication to help them quit, they are expected to continue that medication regardless of how well it is working. In this study we will see if African Americans smokers respond better if they continue with a single treatment or if their treatment is changed when that treatment is not working. The innovative study design evaluates a major shift in the approach to tobacco dependence treatment and, if effective, could have broad treatment implications for the nearly 6 million AA adult smokers in the U.S.